Modeling Chromosomal Mosaicism During Early Human Embryogenesis on Microraft Array Platform

PROJECT SUMMARY/ABSTRACT
Aneuploidy and chromosomal mosaicism in human embryos complicate predicting pregnancy outcomes
already plagued with frequent pregnancy losses. Given the rapid increase of fertility treatments such as assisted
reproductive technology (ART) treatments, there is a critical need to better assess the developmental potential
of embryo candidates, especially in patients with poor prognoses. Both recent clinical and in vitro studies suggest
that human mosaic embryos can selectively eliminate aneuploid cells for healthy development; however, the
mechanisms mediating this embryonic self-correction have yet to be systematically studied in humans. Here, I
propose to investigate the role of autophagy, which regulates both cell survival and death, in aneuploidy
depletion. Although previous work in mouse and human preimplantation models demonstrated autophagy
upregulation in eliminated cell types, our preliminary data in a human gastrulation model revealed that autophagy
instead aids in cell survival. Because both technical and ethical limitations restrict studying cellular processes
during early human embryogenesis, I will develop a novel platform to quantitatively screen and sort mosaic
gastruloids—an in vitro multicellular model recapitulating cell fate and signaling during gastrulation—comprised
of euploid and aneuploid human embryonic stem cells (hESCs). Analyzing single gastruloids is challenging by
most current technologies like gene expression assays, which only allow for low-throughput sorting or bulk
analyses. Thus, new tools are required to systematically study the heterogeneity among gastruloids undergoing
dramatic changes during self-organization.
The project is divided into two main Aims. I will use an automated microscope system that I have
developed to perform image-based phenotypic screens of single gastruloids using live reporters and a custom
computational pipeline. Firstly, I will generate a mixed population of mosaic gastruloids and identify distinct
phenotypes based on patterning behavior via clustering. Secondly, I will investigate autophagy-dependent
aneuploidy depletion within the mosaic gastruloids by measuring autophagy markers (LC3B and p62) and p53-
responsive genes (p53, p21, cyclin G1, bcl-2). The gastruloids will be treated with bafilomycin A1 or rapamycin
to inhibit or enhance autophagy, respectively. I hypothesize that phenotypic abnormalities in mosaic human
embryos are dependent on the degree of aneuploidy present, and that autophagy can prevent the elimination of
aneuploid cells. The proposed project will enable future research to delineate other embryo self-correction
mechanisms critical in overcoming error-prone development and to improve fertility treatments for an increasing
number of patients.

Public health relevance
PROJECT NARRATIVE Human embryos with many genetically different groups of cells present challenges for people facing infertility. Emerging evidence has shown that these embryos with lower levels of genetic abnormalities develop similarly as those with a normal set of chromosomes. Thus, a novel colony screening and sorting platform for detailed studies of how embryos are distinct from each other and remove chromosomal defects is crucial to understand how healthy embryos grow despite frequent errors.